Improving Timely Access to Care for Veterans with Pulmonary Fibrosis Detected on Lung Cancer Screening

Background. Approximately 1.2 million Veterans are eligible for lung cancer screening (LCS) annually. An
estimated 25% (n=300,000) are projected to have non-cancer interstitial lung abnormalities (ILA). ILAs refer to
the presence of radiographic abnormalities suggestive of early interstitial lung disease (ILD), a group of
disorders of progressive lung scarring (i.e., fibrosis). Importantly, not all ILAs progress uniformly and certain
radiographic and clinical features are associated with worse prognosis. However, there is currently no
systematic method for Veterans with ILA detected on LCS to receive follow-up care. Because of a finite number
of pulmonologists in the VA, the healthcare system will not be able to absorb 300,000 Veterans with ILA into
specialty care. To balance finite resources while ensuring efficient access among Veterans at highest risk,
novel techniques to identify, triage, and facilitate follow-up for Veterans with ILA on LCS are needed.
Significance/Impact. The goal of this proposal is to develop a risk prediction model for ILA progression and
mortality to inform the development of a follow-up care pathway embedded within operational workflows that
will facilitate timely access to care for Veterans with ILA detected on LCS. This proposal addresses multiple VA
research priorities including: (1) health systems research topic areas of organization and delivery, clinical
management, and quality, (2) strategic methodology areas of implementation science, data science,
engagement science, and (3) the quintuple aims of improving outcomes, increasing access, decreasing costs,
and supporting a finite workforce. It also addresses the goals of the Promise to Address Comprehensive
Toxics (PACT) Act, which makes access to ILD care, a new military service-connected disability, a priority.
Innovation. The development of a risk prediction model for ILA progression is innovative. Leveraging lung
texture analysis (LTA), a novel validated machine learning tool, to objectively quantify radiographic fibrosis and
inform prediction modeling is innovative. Developing a follow-up care algorithm that integrates risk is innovative
and will facilitate the care of a projected 300,000 Veterans with ILA annually while optimizing clinical efficiency.
Specific Aims. Aim 1: Develop a risk prediction model to inform care triage among Veterans with ILA detected
on LCS. Aim 2A: Establish actionable thresholds for follow-up care informed by clinical risk using a modified
Delphi consensus process. Aim 2B: Conduct patient focus groups to integrate Veteran preference into
communication of findings. Aim 3: Develop and pilot test a follow-up care pathway to facilitate care for
Veterans with ILA and evaluate usability and acceptability of integration with LCS clinical workflows.
Methodology. In Aim 1, we will identify a random sample of 2,000 patients with ILA detected on LCS between
2014 – 2017 and extract 5-year clinical and outcome data (progression, survival) from the electronic health
record. Risk prediction models will characterize the radiographic and clinical features associated with
progression (model 1) and mortality (model 2). In Aim 2, we will (a) convene a panel of 16 clinical experts
through the Pulmonary Fibrosis Foundation Care Network for a 2-round modified Delphi panel to establish
actionable thresholds and guidance for ILA follow-up care and (b) conduct patient focus groups to understand
Veterans preference for communication of incidental findings guided by Forsey et al’s review of patient-
physician communication. In Aim 3, we will develop a follow-up care pathway and conduct formative
assessment to evaluate usability and acceptability of integration within clinical workflows.
Next Steps/Implementation. The long-term goal of this CDA is to facilitate timely access to follow-up care for
Veterans with ILA detected on LCS, prevent underuse or overuse of subspecialty care resources, and improve
morbidity and mortality by developing a workflow for operational partners that optimizes clinical efficiency.
Successful completion of the aims will enable a future implementation-effectiveness study evaluating the
efficacy and impact of our care pathway under the purview of the LCS and Lung Precision Oncology Program.

Public health relevance
Approximately 1.2 million Veterans are eligible for lung cancer screening (LCS) annually. An estimated 25% (n=300,000) are projected to have non-cancer interstitial lung abnormalities (ILA) consistent with early pulmonary fibrosis. There is no systematic method for Veterans with ILA detected on LCS to receive follow-up care. Because not all ILA’s progress uniformly, novel techniques that facilitate access to care while balancing healthcare system resources are needed. In partnership with the Lung Precision Oncology Program, we will optimize clinical efficiency by: (1) developing risk prediction models to inform ILA care triage, (2) establish actionable thresholds for follow-up care using a modified Delphi panel and conduct patient focus groups to integrate Veteran preference into communication of findings, (3) develop an ILA follow-up care pathway and evaluate usability and acceptability within clinical workflows. Successful completion of these aims will support Dr. Bhavika Kaul’s career development and facilitate care for up to 300,000 Veterans with ILA annually.